Core C: Translational and Transformative Research

PROJECT SUMMARY
Nationally, drug overdose is the leading cause of adult accidental death, claiming more lives every year than
every armed conflict since the end of the World Wars. Rhode Island is a state devastated by overdose
mortality and morbidity. The enormity and urgency of the opioid epidemic call for new, translational
approaches, and faster dissemination of research and promising interventions to transform the care of opioid
addiction and overdose, in Rhode Island and nationwide. To maximize the impacts of such scientific findings
on the behaviors of patients, clinicians, healthcare systems, and policy makers, the proposed COBRE on
Opioid Addiction and Overdose needs concerted efforts and key resources to both generate and execute
translational research, and to create effective study dissemination tools. Local resources to encourage and
nurture translational research in the social and behavioral to clinical sciences are limited, and opportunities for
skill acquisition, concept development, simulation, and user testing in translational research are not sustained
over time. To better optimize the efficacy and reach of the proposed projects, resources to generate and
execute translational research, and to create effective study dissemination tools are needed. The Translational
and Transformative (T2) Core aims to provide expert support and technical assistance to junior investigators
and affiliated researchers at Rhode Island Hospital, Brown University, and other area hospitals and institutions.
The long-term goal of the T2 Core is to establish a regional and national hub of translational and transformative
resources capable of supporting junior investigators, COBRE projects, and the broader scientific community as
they bridge theory to promising intervention, and research to practice and policy change for opioid addiction
and overdose. The Core aims are to: 1) Support the execution of high-quality translational and implementation
COBRE-affiliated studies through expert consultation and data collection support on qualitative research,
translating theory into intervention, and technology-driven interventions; 2) Develop a culture of excellence and
innovation in translational and transformative training and research on opioid addiction and overdose by
hosting annual meetings and contests, and quarterly workshops and trainings; and 3) Promote and support
implementation and dissemination of COBRE-affiliated research study findings, by assisting with data
presentation, plans for dissemination, and study communications. Led by experienced and highly productive
researchers with extensive mentoring experience, the T2 Core will inspire innovation in translational and
transformative research, and provide a valuable resource for the COBRE studies.